SHORT RESEARCH EXPERIENCES IN CANCER

The aims of this competitive renewal application are to maintain and expand the present program for students participating in cancer research. The ultimate goal is to increase the number of health professionals, especially those from under-represented minorities, that will pursue clinical and/or research careers in cancer. The current grant award, Nutrition-Cancer Education Program (R25 CA47877) began September 1, 1988 and will end August 31, 1992. The grant award included two program components: Nutrition-Cancer Curriculum (Program I) and Short Research Experiences (Program II). This renewal application addresses the Short Research Experiences only, since Program I is not renewable. During years 01 through 04 of this award, the number of applications to the program have increased each year as has the quality of the students receiving the awards. Additional, there has been a higher percentage of minority student recipients when compared to the percentage of minority students enrolled in the Louisiana State University School of Medicine. In this application, the following activities are proposed: * continued funding for students from the health professions to participate in the Short Research Experiences in cancer/oncology; * expansion of the assistantships from 12 to 18 positions, including two positions for outstanding high school students; * new approaches for the recruitment of minority participation; * modification of the educational component of the Short Research Experiences; * use of newly-developed tools for evaluation of the Short Research Experiences; The above activities will be implemented in order to expand the educational and research opportunities of students in healthcare in Louisiana. It is anticipated that these opportunities will eventually contribute to cancer control in a state with excessive cancer rates, especially among the minorities.